MAE-WEST SCORE Project 1 Population

Project Abstract – MAE-WEST SCORE Project 1
Over the course of life, chronic stressors contribute to multi-organ aging and dysfunction and, ultimately, the
development of clinical disease. Sex remains a critical determinant of the nature and pace of aging and ultimately
longevity. Among mammalian species, it is even more clear that females fundamentally age differently from
males. With advancing chronologic age in humans, differences in biological aging between women and men
become even more pronounced, culminating in the female predominance for a number of important morbid
disease conditions, including notably Alzheimer’s disease and related dementias (ADRD), heart failure with
preserved ejection fraction (HFpEF), progressive chronic kidney disease (CKD), and in turn systemic frailty.
Mechanisms underlying the female predominance for these major morbidities remains unknown and are not
explained by variations in sex hormones or survival bias. Our preliminary work supports a central hypothesis that
sexual dimorphism in inflammatory eicosanoid mediators contribute to sex differences in microvascular
dysfunction and, in turn, to sex differences in age-related multi-organ disease, including for ADRD, HFpEF and
CKD. Elucidating a common pathophysiologic basis for the female predominance of ADRD, HFpEF, and CKD
holds the key to effective interventions for reducing the excess burden of age-related disease in women.
Motivated our findings and the critical need to understand the determinants and drivers of sex differences in
major age-related disease outcomes, we propose to establish the Microvascular Aging and Eicosanoids
– Women’s Evaluation of Systemic aging Tenacity (MAE-WEST) (“You are never too old to become younger!”)
Specialized Center of Research Excellence (SCORE) on Sex Differences, in response to NIH RFA-OD-19-013.
Our goal is to form a robust and sustainable structure of academic activities centered on systematically
interrogating sex differences in the relationship among eicosanoids, microvascular dysfunction, and age-related
end-organ disease, with an initial focus on the microvascular aging effects on brain, heart, and kidney function.
This goal will be achieved by an outstanding collaborative team of clinician-scientists (with expertise in geriatrics,
cardiology, and nephrology), epidemiologists, basic and translational scientists, analytical chemists,
biostatisticians, and bioinformaticians. Leveraging our collective experience, resources, and infrastructure, we
will advance the scientific enterprise through 3 foundational projects aligned and complementary yet
independent. Project 1 will determine the sex-specific relations of eicosanoids with microvascular
dysfunction and incidence of major end-organ disease outcomes in the community. This population
science project will examine longitudinal variation in hundreds of circulating eicosanoids in relation to: (i) discrete
measures of microvascular function; (ii) trajectories of multi-system (neurocognitive, cardiovascular, renal) as
well as global functional decline; and, (iii) incidence of overt end-organ disease (ADRD, HFpEF, CKD) across
aging women and men patient, in two independent community-based cohorts.

Public health relevance
Project Narrative – MAE-WEST SCORE Project 1 With advancing age, women and men age differently; women suffering more from Alzheimer’s disease and related dementias, heart failure with preserved ejection fraction, chronic kidney disease, and frailty. Recent work suggests that small blood vessel-related aging driven by chronic low-grade inflammation may be responsible for these aging disparities for women. Project 1 in the Microvascular Aging and Eicosanoids – Women’s Evaluation of Systemic aging Tenacity (MAE-WEST) (“You are never too old to become younger!”) Specialized Center of Research Excellence (SCORE) on Sex Differences will study pro and anti-inflammatory responses and small vessel aging traits in aging women and men in two independent community-based cohorts, which will improve public health by understanding those most at risk for age-related conditions in the population.